A Next Generation Data Infrastructure to Understand Disparities across the Life Course

Summary
This infrastructure proposal aims to further advance capabilities in the social sciences (broadly defined) to
collect data on the daily lives of U.S. families and individuals. These data will be more accurate, more granular,
and more comprehensive than is currently possible in traditional survey-based research. The context for this is
the Understanding America Study (UAS), the probability-based Internet panel we have been building at USC
since 2014. The infrastructure includes the combination of many data types (including survey data, information
from wearables, contextual and administrative linkages, ecological momentary assessments, self-recorded
narratives, and electronic records of financial transactions), as well as an open communication with the wider
research community both in data dissemination and in soliciting input on content and methods.
The UAS currently comprises about 10,000 U.S. residents (including a 2,500 person California oversample),
recruited by address-based sampling and provided with Internet-enabled tablets if needed. Surveys are
conducted in English and Spanish. We propose to expand the UAS national sample to 20,000 respondents, with
subsamples of Blacks, Asians, and Hispanics of at least 3,000 each.
The information collected will focus on factors explaining racial and socio-economic disparities over the life
course, including racial discrimination, inequalities in access to education and healthcare, differences in the
physical and social environment, and, more generally, the various opportunities and obstacles one encounters
over the life course.
The proposed project team covers a broad spectrum of substantive expertise on disparities, racial
discrimination, environmental health, child development, health, and cognition over the life course, as well as
aging and retirement, consumption, work, and income. To encourage input from the research community, we
envision a program of added survey modules on inequality-related topics proposed by outside researchers, as
well as an annual research conference.
The basic premise underlying the project is that the only feasible approach to comprehensively investigating
the impact of differences in the life course on observed inequality is to enact a robust multi-method approach
that provides the means of accounting for as many explanatory factors as possible. Within that context, naturally
occurring experiments can be exploited to help identify causal pathways of interest (e.g., when air quality in a
neighborhood improves due to a plant closure; a policy change that affects the quality of schools in a certain
area). Thus, our proposed project aims to create and make available to the research community a uniquely
detailed and focused collection of information on U.S. households and individuals. To achieve this goal, we aim
to strategically integrate selected external data sources with UAS survey data and expand the already broad set
of topics covered by UAS surveys.

Public health relevance
Project Narrative The project aims to expand the Understanding America Study to a longitudinal study of at least 20,000 individuals, including adequate sample sizes across different demographic subgroups to enable statistically powered subgroup analysis. Integrating multiple innovative data sources and technologies with the existing robust research infrastructure provides unprecedented opportunities to study the development of health disparities over the life course and to identify approaches to mitigating adverse health effects. Resulting data will constitute a uniquely valuable resource, which will be made available to the research community without delay.